Targeting p300 to Overcome PARP inhibitor resistance induced by acidic tumor microenvironment

Project 4 PROJECT SUMMARY/ABSTRACT
The overall goal of this proposal is to develop a novel strategy to improve efficacy and/or overcome resistance
to PARP inhibitors induced by acidic tumor microenvironment by targeting epigenetic regulator p300. PARP
inhibitors such as olaparib are FDA-approved for the maintenance and treatment of epithelial ovarian cancer
(EOC) patients with impaired homologous recombination (HR) pathways, most notably with BRCA1/2
mutations (also known as homologous recombination deficiency or HRD). However, resistance to PARP
inhibitors remains a major unmet clinical need. This is a hypothesis-driven translational study, and the findings
will be pivotal for evaluating whether IACS16559, a p300 inhibitor developed by the MD Anderson Cancer
Center, in combination with olaparib represents an effective approach to improve efficacy and/or overcome
resistance to PARP inhibitors. Thus, the p300 inhibitor is readily available for immediate translation in ovarian
cancer. Substantial evidence shows that tumors exhibit a lower extracellular pH compared to normal tissues.
Our preliminary data show that acidic extracellular pH causes resistance to PARP inhibitors such as olaparib
in HRD EOC cells. Our CRISPR screen revealed p300, an epigenetic transcription activator, as a top hit
whose inhibition sensitizes cells to olaparib in acidic pH. Mechanistically, our preliminary data indicated that
in a p300-dependent manner, acidic pH suppresses the non-homologous end joining (NHEJ) DNA double-
strand break (DSB) repair pathway and reduces PARP trapping, two well-characterized mechanisms of PARP
inhibitor resistance. Our central hypothesis is that targeting p300 using clinically applicable small molecule
inhibitor IACS16559 is a promising therapeutic strategy to improve the efficacy and/or overcome the
resistance to PARP inhibitors caused by acidic tumor microenvironment in HRD ovarian cancers. Three
Specific Aims are proposed: Aim 1 will investigate a combined therapeutic strategy of targeting p300
and olaparib in HRD EOC cells and patient-derived xenografts; Aim 2 will explore the combination of
p300 inhibitor IACS16559 and olaparib in patients with HRD non-mucinous EOC in a Phase 1 clinical
trial; and Aim 3 will identify biomarkers that correlate with response to IACS16559 and olaparib
combination in HRD EOCs. The proposed studies are highly innovative because they challenge current
research/clinical paradigms for PARP inhibitor-resistant ovarian cancer, contribute to new concepts for
epigenetic therapeutics, reveal new mechanistic insights into the acidic tumor microenvironment, and utilize
innovative methods to explore new intervention strategies for PARP inhibitor resistance in EOC. The
proposed studies are of high impact because they will develop novel therapeutic strategies to improve the
efficacy and/or overcome the resistance of PARP inhibitors by targeting p300 with IACS16559 in combination
with olaparib, a major challenge in the clinical management of ovarian cancer.

Public health relevance
Project 4 PROJECT NARRATIVE The proposed research is relevant to public health because it aims to develop novel ovarian cancer therapeutic strategies with a durable therapeutic outcome to overcome PARP inhibitor resistance by targeting epigenetic regulator p300 using clinically applicable small molecule inhibitor IACS16559. Therefore, the proposed research is relevant to the part of the NIH’s mission that pertains to developing fundamental knowledge that will reduce the burden of human illness.